SAFETY/TOLERABILITY/EFFICACY OF SELEGILINE TRANSDERMAL SYSTEM IN AIDS DEMENTIA

Antiretroviral agents are the only therapy currently used for treating HIV dementia, but the treatment response is often poor. Selegiline is an approved and marketed selective monoamine oxidase type B inhibitor. However, at very low dosages in in vitro and in vivo systems, it blocks the formation of oxygen radicals and has a trophic effect on injured neurons through the stimulation of anti-apoptotic factors. A previous randomized double-blind, placebo-controlled trial of low dose oral selegiline suggested that selegiline treatment is associated with cognitive improvement in subjects with HIV-associated cognitive impairment. This study will evaluate the safety, tolerability, and efficacy of transdermal selegiline in patients with HIV-associated cognitive impairment. Transdermal selegiline has been well tolerated in healthy volunteers and in patients with Alzheimer's disease.